A multi-faceted intervention to promote breast cancer hormone receptor testing in Tanzania

PROJECT SUMMARY/ABSTRACT
Breast cancer outcomes are disproportionately poor in low- and middle-income countries (LMICs)
compared to high-income countries. Low breast cancer survival rates in LMICs are primarily attributable to
advanced stage presentation and limited diagnostic and treatment capacity. Although national clinical practice
guidelines for breast cancer in Tanzania recommend that all breast cancer patients receive hormone receptor
(HR) testing, current pathology capacity is unable to meet this need. Pathologic diagnosis, including HR testing,
is critical to determining the presence of cancer, extent of the disease, and planning treatment. However, HR
testing is available at only two public hospitals in Tanzania. As a result, patients encounter turnaround times of
weeks to months, with only a subset of eligible women receiving HR testing and guideline-concordant treatment.
To reduce this evidence-to-practice gap, we propose to systematically identify the most effective
implementation strategies across all public referral hospitals with pathology services in Tanzania to guide
development of a multi-faceted and adaptable intervention (set of implementation strategies). We hypothesize
that this intervention will increase the proportion of women who receive HR testing and guideline-concordant
endocrine therapy, resulting in improved cancer care, quality of life, and overall short term survival of patients.
First, we will conduct a formative evaluation to determine the organizational readiness for change and
to identify barriers and facilitators to routine HR testing using mixed methods. Then, we will determine the
optimal implementation strategies for the barriers and facilitators identified in the formative evaluation, and
develop a multi-component intervention with methods informed by organizational theory. Finally, we will
iteratively pilot test the multi-component intervention and will modify the intervention components based on
outcomes measures.
These studies will be led by Dr. Dianna L. Ng, a junior faculty member in the Department of Pathology
at Memorial Sloan Kettering Cancer Center (MSK) with an interest in developing and testing theory-driven,
multi-level interventions to increase integration of evidence-based cancer diagnostics in low-resource settings.
The research will be carried out under the multidisciplinary mentorship of Dr. T. Peter Kingham (surgical
oncologist, global oncology research), Dr. Jamie Ostroff (clinical psychologist, implementation science), Dr.
Edda Vuhahula, (pathologist, capacity building in East Africa), and Dr. Britt-Marie Ljung (pathologist, resource-
stratified diagnosis). MSK offers an outstanding environment for cancer care delivery and health services
research. To achieve her goal of becoming an independent researcher, Dr. Ng has developed a structured
career development plan aimed at advancing her knowledge and advanced skills in implementation science in
global health.

Public health relevance
PROJECT NARRATIVE In Tanzania, breast cancer is the second most common cancer and second leading cause of cancer-related death in women. Although hormone receptor testing is recommended in all breast cancers by the recently published Tanzanian National Cancer Treatment Guidelines, testing is available at only two public hospitals, resulting in pathology laboratories that are overburdened and in turnaround times of weeks to months. Using implementation science frameworks, this study aims to identify effective implementation strategies to promote routine hormone receptor testing in low resource settings, and in turn, to improve clinical outcomes by increasing access to guideline-recommended treatment.